Development of New Imaging Tools for the Early Detection of Buruli Ulcer Disease

DESCRIPTION (provided by applicant): Buruli ulcer (BU) is a devastating flesh-eating bacterial infection that, each year, affects thousands of people, mostly children under the age of 15 years. If detected early BU can be easily treated and cured. In the last few years, automated dermoscopy systems have shown promise for accurate detection of skin lesions in the early stages. The objective of this proposal is to develop software tools to analyze suspicious skin lesions to automatically detect BU at an early stage. We propose to 1) collect a well-defined set of BU images using surface illumination with light of different frequencies, 2) develop algorithms for accurate lesion segmentation 3) identify critical features that correlate with surface and subsurface lesion characteristics, such as morphology, color, texture, and subsurface tissue hardening and thickening, 4) develop new classifiers based on implicit mapping with kernels, 5) test the performance of the new algorithms against manual image segmentation and lesion labeling by two domain experts independently. In addition, the proposed project addresses technological and socioeconomic issues, namely (a) the feasibility of deploying sophisticated diagnostic tools on general-purpose devices, such as cell phones which have limited computing power and memory, and employ fixed-point arithmetic, and (b) whether the use of non-descript technology, such as ordinary camera cell phones protects patient privacy, and thus it helps individuals to overcome the social stigma associated with BU so that that they will seek treatment. The proposed project is an important step toward the development of automated tools for identifying key structural features associated with BU. As of yet, no system accomplishes this, and no system has incorporated deep tissue characteristics to identify these structures. If successful, this software will be available as a diagnostic adjunct for deployment on a broad scale. The use of general-purpose devices like cell phones will help improve not only access to healthcare, but also the quality of life of patients, while also minimizing the cost of health care delivery. PUBLIC HEALTH RELEVANCE: Buruli Ulcer (BU) is a devastating and potentially debilitating tropical disease that affects people in more than 30 countries. BU is listed on the WHO list of neglected disease and is treatable and preventable. The development and application of low-cost, ubiquitous, non-invasive technologies that can be used privately by the end user of the local health care provider is critical for (1) increasing access to healthcare and (2) addressing the stigma associated with hospital visits. The success of the project can lower the cost of treatment for this disease and also improve the quality of life of patients.

Public health relevance
Relevance to Public Health. Buruli Ulcer (BU) is a devastating and potentially debilitating tropical disease that affects people in more than 30 countries. BU is listed on the WHO list of neglected disease and is treatable and preventable. The development and application of low-cost, ubiquitous, non-invasive technologies that can be used privately by the end user of the local health care provider is critical for (1) increasing access to healthcare and (2) addressing the stigma associated with hospital visits. The success of the project can lower the cost of treatment for this disease and also improve the quality of life of patients.